PHARMACOKINETICS OF FK506 IN PATIENTS WITH MILD AND SEVERE HEPATIC DYSFUNCTION

The purpose of this study is to characterize the pharmacokinetic parameters opf FK506 in patients with hepatic impairment.